Leveraging Mexican Millipede Secretions as Neuromodulators

Project summary/abstract
New treatments of neurological disorders are desperately needed, especially in regions with significant and
disproportionately unmet needs, such as in Mexico. Although Mexico's incidence of chronic pain is on par with
that in the US, their utilization of current treatments only amounts to 0.56% of the level seen in the US.
Development of natural products from organism's native to Mexico for the treatment of pain has the potential of
fewer perceived risks and may overcome challenges of current therapeutics. The goal of this project is to
establish millipedes as a source of natural products that can be leveraged for the treatment of pain.
The success that natural products have had clinically is due to their ancient evolutionary history; their structures
and functions evolved over millions of years of selection to carry out an essential role for the organism. For
example, many of the antibiotics applied today are produced by terrestrial microorganisms that use them to
vanquish competitors. Millipede natural products are no different. Different millipedes have evolved the ability to
produce unique defensive metabolites, including hydrogen cyanide, oxidized aromatics, and terpenoid alkaloids.
These metabolites change in structural complexity through evolutionary time. Their structural diversity is
correlated with phylogeny, and the conservation of biosynthetic pathways along with the evolution of gland
anatomy to store these metabolites are strong indicators of their important ecological role. The terpenoid
alkaloids, nitrogen containing heterocycles, are the least studied but simultaneously the most interesting from a
biological perspective. Less than 10% of the alkaloid producing millipedes have been investigated and each one
has led to a new chemistry with unprecedented carbon backbones. Most notably, we recently showed that two
different subsets of these molecules bind potently and specifically to two different receptors (sigma-1, and sigma-
2) with each receptor having been implicated for the treatment of neurological disorders, including chronic pain.
Our research team proposes to study millipedes native to Mexico to investigate the relationship between
molecular phylogeny and chemical diversity to uncover novel natural products with important biological activity.
Our team's expertise in millipede ecology specific to Mexico, natural products chemistry, and biochemistry, will
lead to the discovery of millipedes producing new bioactive alkaloids. Novel natural products will be isolated,
structurally characterized, and biochemically evaluated to fully understand their therapeutic potential.
Collectively, our proposed research program will broadly impact the field by showing that millipedes native to
Mexico are a repository of many new biologically relevant natural products. Studying these small molecules will
lead to the discovery of novel sigma-1 and sigma-2 ligands that have the potential to populate the drug pipeline,
specifically for the treatment of chronic pain, without the perceived risks of current treatments.

Public health relevance
Project NarraƟve Most of our medicines are from naturally occurring compounds derived from the animals and plants inhabiting the natural world, including morphine (from the opium poppy) and caffeine (from coffee and others). Our team recently discovered that millipedes naturally produce compounds that have strong binding affinity to a type of human protein associated with pain. Mexico is a global hotspot for diversity of chemically-rich millipedes, and with a team of scientists from Universidad Autónoma del Estado de Hidalgo, Universidad Nacional Autónoma de México, and Virginia Tech, we will sample and screen dozens of these millipedes for these highly distinctive compounds.